Neurophysiological Changes in Pre-clinical Alzheimer's Disease

ABSTRACT
This is a resubmission for a K01 Mentored Research Scientist Award for Dr. Hannes Devos, an Early Career,
Tenure Track Faculty of Physical Therapy and Rehabilitation Science at the University of Kansas Medical
Center. While I have received clinical research training in my postdoctoral years, I seek to expand my scientific
foundation in becoming an independent researcher in applied neurophysiology of Alzheimer's disease (AD).
My primary goal is to attain independence, capable of leading a multidisciplinary group in investigating
neurophysiological markers —event-related potentials (ERP), heartbeat-evoked potentials (HEP), and task-
evoked pupillary response (TEPR)— of early neurodegenerative decline in pre-clinical AD. I am at a critical
point in my career to make this transition after gaining initial experience with pupillometry in Parkinson's
disease. Thus, I am proposing a career development plan in which I will train with renowned experts in clinical
methods (Dr. Burns), neurophysiology (Dr. Gustafson), neuro-imaging (Dr. Brooks and Dr. Burns), and
research independence (Dr. Burns, Dr. Brooks, and Dr. Mahnken).
From these experts' mentoring I will learn: (1) Expertise in clinical methods, including the study of cognitive
changes due to normal aging and neurodegeneration on molecular, cellular, and systems level; (2) Expertise in
neurophysiology of non-invasive brain activity measures such as ERP, HEP, and TEPR; (3) Experience in
neuro-imaging, including the ability to read and analyze MRI and PET data; (4) Advanced experience in
research independence, especially complex statistical analyses, scholarly productivity, and research funding.
The proposed research offers a unique opportunity to (1) compare neurophysiological responses to cognitive
demand between healthy aging, pre-clinical AD, and MCI/AD; (2) correlate neurophysiological responses to
structural brain changes; and (3) examine the intrasubject variability of neurophysiological responses in the
short- and long-term. The central hypothesis is that neurophysiological changes will manifest prior to
decrements in neuropsychological performance in pre-clinical AD, reflecting a compensatory mechanism for
excessive neural recruitment to cope with cognitive task demand. The knowledge gained from my career
development and research training will enable me to compete for R01 funding to investigate neurophysiological
markers of early neurodegenerative, cognitive, and functional decline in pre-clinical AD.
This project will capitalize on KUMC's major research strengths: the NIH-designated Alzheimer's Disease
Center, the Hoglund Brain Imaging Center, and the Clinical and Translational Science Unit (NIH CTSA).
In summary, this K01-award will bring together my clinical research experience and my new skills in applied
neurophysiology of AD. The mentor team and research environment will provide essential support on my track
towards research independence.

Public health relevance
NARRATIVE Non-invasive neurophysiological measures, including event-related potentials, heartbeat-evoked potentials, and task-evoked pupillary response, have the potential to detect early neurodegenerative changes in pre- clinical Alzheimer's disease (AD), even prior to showing up in neuropsychological tests. The relationship between neurophysiological changes, molecular and structural changes, and neuropsychological tests in pre- clinical AD is currently unknown. We propose a cohort study involving older adults with different severities of cognitive decline (cognitively normal healthy adults, cognitively normal pre-clinical AD, mild cognitive impairment, and AD) to (1) test the hypothesis that neurophysiological changes occur prior to the presence of neuropsychological changes in preclinical AD; (2) test the hypothesis that neurophysiological changes are a manifestation of early structural changes in pre-clinical AD; and (3) to examine the psychometric properties of the neurophysiological measures in the short and long term.